Interdisciplinary Biomedical Imaging Training Program

Interdisciplinary Biomedical Imaging Training Program
Abstract
The Interdisciplinary Biomedical Imaging Training Program will prepare predoctoral trainees to become leaders
in organism-level, biomedical imaging technology and application research. Multi-disciplinary teams of engi-
neers, physicists, biologists, and clinicians are required to advance biomedical imaging, especially with the ad-
vent of in vivo cellular and molecular imaging. We will create the next generation of interdisciplinary biomedical
imaging scientists and engineers who will contribute to and lead such teams. Our training program will build
upon continuing, significant institutional, state, federal, and commercial investment in faculty and imaging infra-
structure. A training grant award will place students squarely in the center of on-going interdiscipli-
nary/multidisciplinary research programs. Trainees will use imaging facilities in the Case Center for Imaging
Research which includes state-of-the-art clinical and preclinical imaging systems, along with labs of mentoring
faculty. Predoctoral trainees will be from the highly-rated departments of Biomedical Engineering and Physics,
both of which have a long history of training in biomedical imaging. Trainees will conduct research projects
combining enabling technologies in imaging with biomedical research. Each trainee will have two or more men-
tors representing both imaging technology and biological/clinical applications of imaging. Our educational pro-
gram includes a portfolio of imaging courses, including ones focusing on imaging physics, image analysis, and
reconstruction, as well as nanomedicine. We will promote a culture of interdisciplinary research during a desig-
nated Imaging Hour. Our T32 has enabled us to increase recruitment of women and under-represented minori-
ties. In general, it has helped make graduate students cost effective as compared to post docs and ensured
training of domestic PhD’s in this area of critical need. In less than nine years, our T32 program has already
successfully trained several graduates, all with exemplary training records and with a trajectory towards suc-
cess. Other trainees are moving through the program focusing on exciting interdisciplinary imaging research
and with excellent research productivity.

Public health relevance
Relevance to Public Health. Biomedical imaging enables early disease detection, assessment of therapy, and minimally invasive treatment of disease. Especially with the advent of cellular and molecular imaging and machine/deep learning, biomedical imaging research requires persons with strong interdisciplinary training.